Planning & Evaluation

PROJECT SUMMARY/ABSTRACT
The Winship Cancer Institute of Emory University (Winship) planning and evaluation process, overseen by the
Executive Director, Walter J. Curran, Jr., MD, is responsible for the systematic planning and evaluation of
Winship, its research programs, shared resources, clinical research enterprise, and clinical operations. Winship
relies on the input of expert internal and external consultants and leaders to plan and evaluate its strategic
research priorities and for the assessment of the progress of research programs, impact of shared resources,
administrative support, and organizational structure. These activities are directed internally by the Winship
Internal Advisory Board and the Winship Executive Committee. An External Advisory Board (EAB) is composed
of a renowned group of cancer center directors, program leaders, researchers, and administrators from other
NCI-designated cancer centers across the country. The EAB is charged to provide critical evaluation of Winship’s
activities and strategic plan. During the current funding period, input from each of the boards and committees
discussed in this section Winship to improve processes and elevate the level of its science. Thorough planning
and evaluation has led to the development of the Winship 2016 – 2018 Strategic Plan. The plan will guide the
centers continued develoment during the next funding cycle. The funds requested in addition to committed
institutional funds will provide support for these important advisory endeavors.